The Characterization of RNA Binding Motif Protein 48 (RBM48) in U12 Intron Splicing, Cellular Differentiation, and Development

PROJECT SUMMARY
The project aims to improve our understanding of the role of a novel RNA Binding Motif Protein 48 (RBM48) and
its impact on cell proliferation and differentiation. RBM48 represents a core minor spliceosomal protein essential
for the splicing of minor or U12-type introns, constituting a small fraction of deeply conserved introns. The
splicing of U12 introns has a similar role in cell differentiation across divergent eukaryotes. However, the
mechanism by which U12 splicing controls these cell differentiation pathways is poorly understood. Our prior
work demonstrated that the disruption of orthologous RBM48 in humans and plants disrupts the splicing of
multiple minor intron-containing genes (MIGs). The aberrant splicing of U12 introns in human hematopoietic
stem and progenitor cells (HSPCs) adversely impacts normal myeloid cell differentiation, which is proposed to
be associated with myelodysplastic syndrome and subsequent onset of acute myeloid leukemia. Human RBM48
encodes multiple transcript isoforms by alternative splicing; however, the biological relevance of this process and
the role of transcript isoforms is unclear. The proposal aims to implement cellular, genetic, genomic, and
bioinformatic tools to investigate the mechanistic role of RBM48 and its transcript isoforms in U12 splicing. The
proposal will also examine how RBM48 modulates U12 splicing in HSPCs, directly affecting differentiation,
engraftment potential, and self-renewal of this stem cell population. The data generated will no doubt bridge the
gap in our understanding of a growing number of diseases ranging from hematological and neurological to cancer
that have been linked to defects in U12 splicing. In Specific Aim 1, we will use a developed genetic assay in
human K562 leukemia cells to determine the functional role of RBM48 transcript isoforms in U12 splicing and
implement mRNA-seq-based transcriptomic data to determine impacted genes and downstream processes that
regulate U12 splicing mediated cellular differentiation. In vivo and in vitro protein-protein interactions of RBM48
transcript isoforms will be used to elucidate the mechanistic role in U12 splicing. The data will lead to a better
definition of U12 intron consensus and potentially identify sequence targets of RBM48. We have shown that
RBM48 knockdown alters the survival and proliferation characteristics of K562 cells. In Specific Aim 2, we will
use an RBM48 knockdown strategy in HSPCs to demonstrate its essential role in U12 splicing mediated impact
on differentiation, cell fate determination, and self-renewal potential. We will use a combination of phenotypic
and in vivo and in vitro functional assays to accomplish these outcomes. By completing the proposed study, our
long-term goal is to enhance our understanding of how U12 splicing regulates cellular differentiation, which will
enable us to identify new drug targets and lead to robust treatment strategies for patients suffering from a growing
number of diseases attributed to aberrant splicing of U12 introns.

Public health relevance
NARRATIVE Minor or U12 introns constitute a rare group of introns spliced by a distinct minor spliceosome and mutations that disrupt U12 splicing cause developmental defects in humans and plants. An RNA Binding Motif protein 48 (RBM48) encodes several transcript isoforms and has a conserved function in U12 splicing required for normal growth and cell differentiation, but the mechanism of this process is unclear. This project will elucidate the functional role of each RBM48 transcript isoform in U12 splicing and identify genes and downstream processes impacting this action, and will also define how RBM48-mediated U12 splicing in hematopoietic stem and progenitor cells impact cell fate determination, differentiation, and self-renewal potential, with a long-term goal to understanding the mechanism by which U12 splicing modulates these cellular functions and impact human health.